Clinical - Translational Core

PROJECT SUMMARY – CLINICAL TRANSLATIONAL CORE
The Clinical/Translational Core provides an infrastructure and resources for human translational and patient-
oriented research. This is accomplished in part by providing translational resources for liver investigators who
are basic scientists, such as making bio-specimens available and offering iPSC’s/liver organoids derived from
patients with specific diseases. The Core is useful for clinical researchers as well, who also make use of bio-
specimens and our patient registry, plus the services of our research coordinator and statisticians. Therefore,
the Clinical/Translational Core advances the science and practice of Hepatology through the following specific
aims: (1) Provide resources necessary to support clinical and translational research, specifically: (a)
biostatistical support, including study design and data analysis, with plans to increase expertise in database
research, (b) bioinformatic support, including analysis and interpretation of whole-exome and whole-genome
sequencing, RNA-seq, single cell RNA-seq, microRNA-seq, ChIP-seq, and 16S/18S and shotgun
metagenomics, (c) patient registry and biospecimen repository, with recent extension of this repository to include
peripheral blood mononuclear cells (PBMC) that can be transformed into iPSCs, as well as human bile, both of
which can be used in the creation of liver organoids, and (d) staff support, including a research coordinator who
can help locate/retrieve biospecimens from the liver center repository or from other relevant repositories at our
institution, and a liver pathologist, who is available for consultation, retrieval and review of archived clinical
specimens, and interpretation of other tissue specimens, such as from animal models. (2) Provide the
environment in which high-quality clinical and translational research will be centered, thereby translating
knowledge from basic science to clinical research, contributing to the development of young clinical investigators
and creating collaborations among center members and other members of the scientific community interested
in research relevant to liver. As a result of these efforts, half of the members who now use this core are laboratory-
based investigators, and all center members who currently use this core collaborate with other center members.